Molecular Characterization Of A Large Cross-Sectional And Longitudinal Collection of Patients To Investigate Disease Progression in IC/BPS

PROJECT SUMMARY
The studies proposed here represent a continuation of our molecular and clinical phenotyping work in a large
and diverse interstitial cystitis/bladder pain syndrome (IC/BPS) patient population. We present preliminary
data suggesting that IC/BPS comprises at least two distinct phenotypic subpopulations; one characterized as a
bladder-centric disease process and the other characterized as a systemic pain syndrome. The significant
variability in symptoms and associated syndromes (i.e. disease heterogeneity as well as disease severity)
among IC/BPS patients contributes to the difficulty in developing targeted therapeutics. Therefore, we propose
to leverage a large repository of retrospectively and prospectively collected unique clinical specimens (bladder
biopsy tissue and peripheral blood from >400 IC/BPS patients and >100 non-IC controls) to identify molecular
mechanisms that define patient subgroups. This will be accomplished by using a sophisticated molecular
profiling scheme (weighted gene co-expression analysis network, WGCNA) to correlate the transcriptome with
individual patient clinical data as an unbiased means to stratify patients into clinically relevant subgroups for
which potential therapeutic targets will have been identified in the process.
A second objective of these studies is, through gene expression profiling of longitudinally collected patient
samples (bladder mucosal biopsies) compared with change/progression in patient clinical characteristics (e.g.
duration of symptoms, pain and symptom scores on validated questionnaires, anesthetic bladder capacity), to
identify molecular targets and biological pathways that are suggestive of disease progression in IC/BPS.
To accomplish these objectives we propose three Specific Aims. Aim 1: Identification of molecular
signatures that correlate with disease progression in IC/BPS. Analysis of tissues from 300 patients
will provide a representative cross-section of the extensive phenotypic variability seen in IC/BPS. The use of
unbiased weighted gene co-expression network analysis (WGCNA) will allow us to identify gene expression
signatures that correlate with clinical features associated with disease progression. Aim 2: Identification of
a blood-based molecular signature indicative of disease progression in IC/BPS. In this Aim we will
evaluate blood collected from the same 300 IC/BPS patients (and 100 controls) in SA1 to identify a blood-
based molecular signature that correlates with disease severity and is indicative of disease progression. We will
also determine whether blood molecular signatures correlate with bladder mucosal molecular signatures,
which may provide higher resolution phenotypic classification than current clinical measures. Aim 3:
Identification of molecular signatures that predict disease progression in IC/BPS. We
hypothesize that gene expression in the bladder mucosa of IC/BPS patients reflects disease status and that,
over time, changes within an individual may indicate disease progression. We will identify groups of genes that
predict disease progression using unbiased WGCNA of RNA-Seq data from longitudinal patient samples.

Public health relevance
NARRATIVE Interstitial cystitis/bladder pain syndrome (IC/BPS) represents a potentially life-long condition that is challenging to diagnose, difficult to treat, and often results in a severely diminished quality-of-life. Due to the large variation in disease pathogenesis and progression, each of the numerous first, second and third line therapies achieve a sustained positive response in a very limited number of patients. Therefore, the objectives for this proposal are to use a sophisticated molecular profiling approach, in a broadly heterogeneous group of IC/BPS patients, to: (1) identify patient subgroups that share a similar disease etiology and are therefore likely to respond, as a group, to therapy that targets the underlying mechanism and, (2) identify gene expression modules that are predictive of disease progression in IC/BPS.